Impact of Gut Epithelial Serotonin on Afferent Neuron Function and Visceral Pain Signaling

PROJECT SUMMARY/ABSTRACT
Visceral pain is a debilitating symptom of irritable bowel syndrome (IBS), a highly prevalent disorder that
impacts >11% of people worldwide. Visceral pain results from increased excitation of extrinsic primary afferent
neurons (ExPANs) that project from the intestinal tract to the spinal cord. Clinical and experimental evidence
suggest that IBS-related pain is caused, at least in part, by dysregulation of serotonin (5-HT), a key regulator of
ExPAN sensitivity; however, current strategies to modify 5-HT signaling as a pain therapy have limited efficacy
and significant adverse effects. To determine how 5-HT can be better targeted for visceral pain treatment, the
proposed studies focus on the impact of gut epithelium-derived 5-HT on ExPAN function. Enterochromaffin
(EC) cells of the epithelium produce most of the 5-HT in the gut, which stimulates ExPANs to promote sensory
signaling. The serotonin reuptake transporter (SERT), present throughout the gut epithelium, rapidly
inactivates 5-HT. My preliminary data strongly suggest that epithelial-restricted 5-HT modulation is a promising
target for pain therapy that would limit adverse effects. With the support of a K01 Mentored Research Scientist
Development Award, this proposal will define how epithelial 5-HT impacts ExPAN signaling to produce pro- or
anti-nociceptive effects. I will accomplish this in two specific aims, with mentored training in electrophysiology,
single cell molecular analysis, and biophysical assays to assess 5-HT receptor trafficking. Aim 1: How does gut
epithelial 5-HT regulate ExPAN activation? I will determine how availability of epithelial 5-HT impacts ExPAN
mechanosensitivity and excitability, which are neuronal properties that directly influence pain perception. Aim
2: Does gut epithelial 5-HT regulate expression and function of ExPAN 5-HT receptors? I will determine how
increased epithelial 5-HT affects 5-HTR signaling and trafficking in ExPANs, which will have the potential to
reveal intracellular targets for visceral pain treatment. My mentoring team and I have designed this proposal to
provide me with the necessary research training and professional development to establish an independent
academic career in the fields of neurogastroenterology and pain signaling.

Public health relevance
PROJECT NARRATIVE Visceral (i.e., abdominal) pain is a debilitating symptom of prevalent gastrointestinal disorders such as irritable bowel syndrome, and current treatments are ineffective. The proposed experiments will define how serotonin in the gut influences pain sensing neurons and investigate novel therapeutic mechanisms for visceral pain treatment.